Assessing the Pulmonary Toxicity of Microplastic Fibers Complexed with Azo Dyes

PROJECT SUMMARY
Microplastics are now recognized as significant emerging environmental pollutants. A subset of microplastics,
microplastic fibres (MPFs), originate from a variety of sources, including their extensive use in textiles. Due to
their high volume use, MPFs contribute significantly to microplastic pollution of the environment on a global
scale. Much of the toxicity and health effects data on MPFs had been directed towards oral exposures whereas
studies associated with inhalation of MPFs are scarce despite epidemiological evidence and more recent work
that has measured MPFs in air. These studies suggest that inhalation exposures are of equal importance to
explore. In addition, these fibers are known to harbor chemical additives, such as azobenzene disperse dyes
(ADDs), that may contribute significantly to toxicity. Studies examining the damage of ADDs to the human
pulmonary system are limited, and no studies have characterized the toxicity of MPFs that harbor ADDs in the
context of human inhalation exposures. Therefore, as one of the first studies to investigate the toxicity of MPF-
containing ADDs we propose to quantify the toxicity of these agents, singly and in combination, to advanced
lung cell cultures via a custom and unique aerosol delivery and exposure system in vitro and determine the
pulmonary effects in vivo. We will focus on mechanisms associated with classical fiber-based toxicity
(pulmonary fibrosis) and on allergic airway disease (asthma) as ADDs are presumed to be chemical sensitizers
(based on dermal studies) and no studies have examined these dyes in this context. Therefore, we propose
the first studies to investigate the toxicity of MPF-containing ADDs to determine whether toxicity is dominated
by classic pro-fibrotic mechanisms (MPFs), respiratory sensitization (ADDs) or both (mixed phenotype). We will
test the overall hypothesis that that the most significant acute lung toxicity of dyed MPFs is attributed to
ADDs that leach from the fibers and act as respiratory sensitizers. Furthermore, respiratory
sensitization is driven, in part, through ADD-protein adduct formation in lung cells, which manifest as
allergic airway disease. Our approach encompasses 2 specific aims; the first to assess toxicity and
associated mechanisms (protein adduct formation) in vitro through aerosolized fibers (undyed and dyed) to
complex epithelial and immune cell cultures; the second aim will focus on documenting pulmonary toxicity in a
mouse model of asthma. These studies would fill a critical void in our understanding of the hazards posed by
ADD-containing MPFs and such lines of research will lead to a better understanding of long term health
consequences and improved risk assessment.

Public health relevance
PROJECT NARRATIVE Exposure to microplastic fibers that are embedded with azobenzene disperse dyes (ADD) may be associated with lung injury that includes allergic airway disease. This application investigates the potential toxicity of aerosolized textile-relevant ADD dyed microplastic fibers to the lung and associated novel mechanisms that include ADD protein adduct formation. Such first time information crucial to understanding long-term health effects of microplastic fibers.